Nebraska Center for Heart and Vascular Research

Project Title: Nebraska Center for Heart and Vascular Research
Project Summary: Overall Center Organization and Management Plan
Heart and vascular diseases (HVD) are the leading cause of death and hospitalization in the United States,
Nebraska included. The goal of the Nebraska Center for Heart and Vascular Research (CHVR) is to build
the physical and intellectual resources at the University of Nebraska Medical Center (UNMC) to propel the
ability of our faculty to conduct research that drives the heart and vascular disease (HVD) field forward. Our
center has exceptional institutional support, is well-aligned with UNMC’s areas of research emphasis, and we
have an outstanding baseline cadre of investigators with expertise in HVD disease. The main objective of this
Phase I COBRE is to develop a center that promotes and supports excellence in HVD research through the
development of early career researchers, promotes collaborative research that is critical to solving complex
research problems, and expands support for all HVD research with cutting edge infrastructure and mentoring
activities. We have selected research project leaders with research projects that have a strong connection to
the focus of the COBRE and are poised to become independent researchers. The COBRE will maximize the
ability of the Center to boost HVD research at UNMC, enhance faculty research trajectories, mentor early
career investigators to productive research careers, and reduce barriers to research to drive discovery. The
Center has brought together the full range of cutting-edge expertise needed to accomplish our mission and
assembled a strong mentoring program that will train mentors in best practices. To catalyze cutting edge HVD
research the Center will support existing resources and grow new ones like the proposed Bioassay Core
focused on the targeted examination of proteins. With these goals and the Phase I COBRE funding, the Center
will support the infrastructure required for cutting-edge HVD research, increase the number of funded
researchers, and total HVD funding to promote a reputation and culture of excellence in HVD research that can
improve patient outcomes and reduce HVD health disparities.

Public health relevance
Project Narrative: Overall Center Organization and Management Plan The Nebraska Center for Heart and Vascular Research Phase I COBRE will build and expand the capacity of University of Nebraska Medical Center to conduct innovative and groundbreaking heart and vascular disease (HVD) research by growing HVD resources and funded HVD-focused faculty in an environment of collaboration that has the capacity to improve heart and vascular disease outcomes across Nebraska and beyond.